Exogenic organs in gene edited pigs

PROJECT SUMMARY
Endstage heart failure is a common cause of death in the U.S. and worldwide. The only curative therapy for
end-stage heart disease is heart transplantation. Millions of patients (worldwide) could benefit from such
therapy but are not eligible for transplantation due to limited donor organ availability. Therefore, there is an
urgent need to develop alternative organ sources for cardiac transplantation. The long range goal and the
clinical significance of this proposal are to use our newly engineered NKX2-5/TBX5/HAND2 knockout pigs as
hosts ultimately for the production of personalized human hearts for clinical applications. The goal of the
current application is to establish a nonhuman primate platform in a pig that would provide the feasibility for
engineering a humanized heart in a gene edited pig. Our previous publications demonstrate the rationale and
feasibility for our approach. Using CRISPR/Cas9 gene editing technology, we have established that NKX2-
5/TBX5/HAND2 mutant porcine embryos lack a heart and are lethal early during development. Using
blastocyst complementation and SCNT we have further demonstrated that we can rescue the null phenotype
and produce a viable chimeric pig with normal cardiac function. In these proposed studies, we will utilize a
number of emerging technologies to engineer a paradigm shifting nonhuman primate heart in a genetically
modified porcine surrogate. To examine our hypotheses, we will address the following specific aims: Specific
Aim #1: To examine the capacity of GFP-labeled MHC mismatched porcine stem cells to rescue the
porcine NKX2-5/TBX5/HAND2 null embryo; Specific Aim #2: To examine the capacity of interspecies
(macaque iPSCs) stem cells to rescue the NKX2-5/TBX5/HAND2 null porcine host in vitro and Specific
Aim #3: To generate a macaque heart in the NKX2-5/TBX5/HAND2 null porcine host. In these studies, we
will use state-of-the-art gene technologies and macaque GFP-labeled stem cell populations to engineer a
nonhuman primate heart in a gene edited pig. This nonhuman primate large animal model will be an important
resource for regenerative medicine and will serve as a platform for generating personalized humanized porcine
models. This strategy has the capacity to have a profound impact on the development of emerging therapies
for endstage heart failure and transplantation. Given the tremendous morbidity and mortality of cardiovascular
disease in our society, this proposal could have a transformative impact on the field of cardiac transplantation
and the democratization of organ availability for our patients.

Public health relevance
PROJECT NARRATIVE Heart disease is common and deadly; the goal and the clinical significance of this proposal are to develop genetically modified pigs as hosts for the production of a nonhuman primate heart. This nonhuman primate-pig model will be an important resource for regenerative medicine and will serve as a platform for the future generation of a humanized heart in a pig. Given the tremendous morbidity and mortality of cardiovascular diseases in our society, the potential impact of this proposal is tremendous.